Developmental Funds

Developmental Funds are critical to the future progress of the OSUCCC. During the prior funding period, the OSUCCC benefited from $1,936,630 in CCSG developmental funds. For the $485,000 of CCSG dollars used for faculty recruitment, the return to-date in total direct costs for CCSG-approved peer-reviewed extramural funding is $ $45,962,763, a 95:1 return on investment, and in total funding was $48,888,138, a 100:1 return on investment (Table 1). In addition, we used CCSG funds to establish three shared resources, the Pharmacoanalytical Shared Resource, the Biomedical Informatics Shared Resource and the Small Animal Imaging Shared Resource. A brief summary ofthe progress with these three facilities is described below. Their operations as fully established shared resources are described in Section 9.0 of this application.